Indole dysbiosis and mucosal inflammation

Project Summary/Abstract
Mucosal inflammatory diseases such as Crohn's disease and ulcerative colitis, collectively termed
Inflammatory Bowel Disease (IBD) remain among the most debilitating chronic disorders of the western world.
It is estimated that more than 3 million Americans suffer with IBD, with incidence rates on the rise in many
populations. The precise etiology of IBD is not known but emerging evidence implicates shifts in the
constellation of microbes in the intestine (dysbiosis) as a contributing factor.
This proposal is focused on a precise understanding of the role of microbiota-derived molecules in
promoting intestinal resiliency during ongoing inflammation. In particular, we have identified a class of
microbiota-sourced molecules derived from dietary tryptophan, termed indoles, that contribute fundamentally to
mucosal barrier function and wound healing. Our work in progress has focused on defining endogenous host
molecules that interact with indole(s) and become potential targets for the development of new drugs to treat
IBD. Ongoing unbiased work has identified neutrophil myeloperoxidase (MPO) as a candidate target for
indole(s) with potential importance in promoting healthy barrier function.
In this proposal, we hypothesize that this indole-MPO axis determines the extent of bystander tissue
damage in active mucosal inflammation. Three synergistic specific aims are proposed to address this goal. In
Aim 1, we will profile the direct impact of neutrophil MPO on epithelial tight junction proteins in modeled
inflammation. Aim 2 will elucidate the specificity of indole derivatives on MPO inhibition and suppression of
epithelial junctional damage. Specific Aim 3 will test the indole-MPO axis in multiple models of intestinal
inflammation. Results from these experiments will provide new insights into innate regulation of mucosal
barrier and an expanded physiological role for indoles produced by commensal bacteria. The studies proposed
in this project are intended to elucidate a novel role for microbial metabolites in innate immune responses
during mucosal inflammation using in vitro and in vivo models. This work will provide new insight to the
development of improved therapeutic approaches for treating IBD.

Public health relevance
Project Narrative Inflammatory Bowel Disease (IBD), including Crohn's disease (CD) and ulcerative colitis (UC), is a family of gastrointestinal disorders that result from abnormal immune responses to luminal antigens in genetically- susceptible individuals. IBD represents a disease of major interest, with more than 3 million American afflicted with this chronic inflammatory disorder. The proposed studies are designed to understand the extent of tissue bystander damage associated with cells of the innate immune system. These studies will also examine how metabolites of bacteria found in the lumen (i.e. the “microbiota”) prevent or dampen bystander tissue damage associated with acute and chronic inflammation. Such studies should provide new insight into why inflammatory diseases develop, and in particular, how innate immune responses contribute to mucosal inflammation.